3D Bioprinted lung cancer models for drug screening

We have established protocols for the bioprinting of a lung vascularized basal tissue using primary lung endothelial cells, pericytes and fibroblasts. IHC and fluorescence microcopy was used to establish vasculogenesis and angiogenesis. We also developed protocols for the labeling of cancer cells with lentivirus transduced florescence proteins and monitor tumor formation in the tissue for a set of NSCLC cancer cells and use fluorescence microscopy with a image analysis framework to quantitate tumor growth rate, localization relative to vasculature and effects of the tumor cells on vasculogenesis/angiogenesis. We are now planning to screen an oncology collection of ~ 1000 compounds to identify compounds that prevent tumor viability in this tissue model. We are also incorporating macrophages to investigate whether this immune cells modulate tumor growth and pharmacological responses.